New tools for the characterization of gene predictions in prokaryote genomes: app

DESCRIPTION (provided by applicant): We propose to develop new algorithms for gene-finding and characterization in prokaryote genomes applied to the discovery of mini-genes in Pseudomonas aeruginosa. Gene-finding algorithms for prokaryote genomes typically use detailed empirical models of gene structure that do not explicitly provide information on the features that identify a coding region. Furthermore, their performance is usually evaluated based on their ability to recognize known or pre-annotated genes, making reliability of individual predictions difficult to evaluate for genes of unusual composition. Complexity of the underlying models and the size of genome annotation-tasks lead to uncharacterized annotation of non-conserved ORFs that may constitute up to 70% of all annotated genes in a genome. This is a significant limitation especially for comparative genomics, where hypothetical genes predicted by different research groups using different methods and criteria must be compared. Hence, gene prediction tools that complement existing methods by emphasizing transparency and compositional characterization should be useful for improving genome annotations, for evaluating the compositional properties of the predicted genes, and for assigning confidence levels to predictions of hypothetical genes. To achieve this goal we propose to develop new gene characterization procedures that explicitly identify and interpret gene compositional properties. Although we focus in this proposal on its application to prokaryotic genomes, the method will also be ideally applicable to the characterization of metagenomics and RNA-seq data, and to fast detection of coding regions in eukaryotic sequences. An agile navigational bioinformatics tool will also be developed to facilitate editing of genome annotations; to identify problem-regions of automated annotations; to obtain measures of significance of the predictions; and to highlight local sequence features such as start codons, ribosomal binding sites, promoter regions, palindromic sequences. We are specifically interested in applying our approach and tools to identify short genes of unusual composition in strains of Pseudomonas aeruginosa, an opportunistic pathogen that is vigorously studied at the University of Florida. The genome of P. aeruginosa is an ideal candidate to apply our method for its high compositional bias and for its high content in uncharacterized hypothetical genes. Unusual regulatory genes have been recently identified in P. aeruginosa that have escaped annotation because of their small size and unusual composition. Many other genes of similar properties may still have to be discovered. Preliminary applications of our method to the genome of P. aeruginosa has provided significant evidence for many newly identified small genes, providing focused targets for experimental verification and evidence of a widespread role of mini-proteins in regulating gene expression. We expect that application of our methods to the study of P. aeruginosa will result in significant improvements in our understanding of the biology of this important pathogen. We expect that the method will be useful in a wide variety of other applications.

Public health relevance
PUBLIC HEALTH RELEVANCE: The objective of this proposal is to develop gene-characterization tools for prokaryote genomes geared at the identification of genes of unusual composition. The tools will be applied to the identification of short coding sequences ("mini-genes") in Pseudomonas aeruginosa. Our studies are relevant for gene-finding development and for understanding the role of mini-proteins in P. aeruginosa. Project Narrative The objective of this proposal is to develop gene-characterization tools for prokaryote genomes geared at the identification of genes of unusual composition. The tools will be applied to the identification of short coding sequences ("mini-genes") in Pseudomonas aeruginosa. Our studies are relevant for gene-finding development and for understanding the role of mini-proteins in P. aeruginosa. __SpecificAimsTextDelimiter__ Specific Aims We propose to develop innovative bioinformatics methods for the identification and characterization of coding sequences in prokaryote genomes, to disseminate our methods implementing them in user-friendly tools for genome analysis and annotation, and to apply them to the identification of small genes in Pseudomonas aeruginosa. Our approach will separate this from previous efforts by seeking to identify coding sequences using global effects of selection constraints and mutational biases in creating periodic contrasts in the compositional properties of codon positions. Our approach complements available algorithms that base their predictions on complex compositional rules and dependencies empirically learned from a set of bona fine genes. Although these approaches can make maximum likelihood assignments and have reached considerable success, their predictions are difficult to explicitly justify and depend on one or few gene models. Hence it is unclear how successful these methods can be in identifying genes of anomalous composition. By identifying simpler compositional contrasts predicted to arise in coding sequences through mutation and selection, we can identify in a genome sequence potential coding regions independently from detailed compositional models and explicitly characterize the features that suggest each prediction. Furthermore, we can express compositional properties of coding regions as a function of the local compositional properties of the genome, accounting for the well-known dependence of gene content on mutational biases. We plan to apply our methods to the identification of mini-genes in the genome of Pseudomonas aeruginosa. P. aeruginosa is an opportunistic pathogen of growing nosocomial importance well-known for the plasticity of its genome, its adaptability to different environmental conditions and its ability to develop genotypes and phenotypes that resist host reaction and antimicrobial treatment. Because of its growing importance for health and its interesting mechanisms of adaptation, P. aeruginosa has been intensely studied and the genome sequences of several of its strains have been sequenced, providing a rich source of information for bioinformatics and experimental analyses. However, much remains to be understood about the coding potential and mechanisms of adaptation of P. aeruginosa, whose genome still contains a great fraction of uncharacterized genes. We are particularly interested in the identification and characterization in P. aeruginosa of genes coding for small (d 100aa) proteins ("mini-proteins"). Some of these genes have been recently characterized by one of us (SJ) as members of novel classes of regulators of gene expression but the extent of this families in the Pseudomonas genomes remains to be verified. The small size of these genes and the highly GC-biased genome of P. aeruginosa constitute an ideal challenge for application of our approach to gene finding. Our research proposal will center on the following three specific aims: Aim 1. Development of computational methods for the prediction and characterization of coding sequence. Computational methods and software will be developed for the characterization of genes, based on expected compositional contrasts resulting from mutation and selection processes and as a function of compositional biases. The predictor will explicitly identify the gene compositional properties leading to its identification and provide measures of reliability. Aim 2. Development of a visual and analytical tool for genome explorations and gene annotation. Compositional analyses and annotations will be facilitated by implementing the gene-characterization engine in a sequence browser that will perform and display sequence analyses. The tool will have different functionalities, including de novo prediction and refinement of pre-compiled annotations by their comparison with sequence features related to coding. Aim 3. Comparative genomics and identification of mini-genes in Pseudomonas aeruginosa. a. We will apply our methods to the identification of potential mini-genes in the genome of P. aeruginosa. b. Expression of newly characterized genes will be experimentally verified by knock-out and over-expression experiments. We expect that our research, providing new conceptual and computational tools for the analysis of prokaryotic genomes, will significantly affect gene prediction and the annotation process. We also expect that these tools will be most useful in the future to analyze metagenomics and RNA-seq data. We also expect that application of our methods will significantly improve our knowledge on the presence, role and conservation of mini-proteins in Pseudomonas aeruginosa, with profound and wide-ranging implications for human health.